SAFETY AND EFFICACY OF ZENECA ZD859#1 @% VERSUS MS04 INJECTION

To determine if Zeneca ZDO859 #1 2% versus high-dose morphine sulfate injection significanlty alters ionized calcium or parathyroid levels when administered for the sedation of subjects with severe head injury.